Determine the Role of Microglia in Adult Circuit Remodeling in a Mouse Model of Whisker Denervation

Project Summary
Denervation injuries lead to altered neural activity in sensory processing regions of the brain. Recovery from
these injuries is achieved by learning new motor skills to perform tasks of daily living; this requires successful
cortical remapping. This remapping is thought to be mediated in part by changes in thalamocortical (TC)
connections from the thalamus to cortex. However, the reasons that some patients recover well while others do
not is poorly understood. Microglia shape circuits during development by pruning synapses in an activity
dependent manner. Neurons and other cells express “eat me” and “don’t eat me” signals that act through
microglial receptors to guide removal of underused synaptic connections such as those arising from the
denervated body part. Large scale activity changes in sensory circuits after denervation injury lead to altered
signaling through these microglial receptors, altering the activity and function of synapse-associated microglia.
However, it is poorly understood how microglia coordinate with neurons to direct adult cortical circuit
reorganization after peripheral injury. The goals of this project are to determine the necessity of microglia for
post-injury adult circuit reorganization, determine the impact of aberrant signaling from unpruned connections,
and identify the molecular mechanisms microglia and neurons utilize to coordinate their activity with other cells
in the brain. To understand how microglia mediate post-denervation circuit remodeling, we will use a mouse
model of unilateral infraorbital nerve transection (IONX). IONX mimics many aspects of circuit remodeling that
occurs after unilateral denervation injury. We hypothesize that IONX causes microglia-mediated TC remodeling
in the deprived somatosensory cortex of adult mice. This remodeling is expected to cause behavioral
adaptations, particularly related to orofacial sensory/motor function. We will address this hypothesis by 1)
determining the necessity of microglia for TC synapse density changes after IONX. Using tissue collected from
acute, subacute and chronic timepoints, we will quantify changes in thalamocortical input density within the
deprived somatosensory cortex, and microglial association with and removal of TC synapses. We will then
deplete microglia to establish if microglia are required for the changes in the deprived somatosensory cortex.
We will assess orofacial function in sham and IONX mice to demonstrate the impact of microglial TC circuit
reorganization on behavioral adaptations. We will also modulate the activity of TC connections in the deprived
somatosensory cortex to establish that preserved, erroneous activity after IONX leads to orofacial dysfunction.
2) We will use gene expression to identify the mechanisms by which microglia and neurons influence adult
circuit remodeling after injury, such as identification of inactive synapses and increased phagocytosis. The
findings of this proposal will improve our mechanistic understanding of how cells in the adult brain adapt to
peripheral denervation injury, and can be used to gain insight into healthy adult plasticity.

Public health relevance
Project Narrative Loss of peripheral sensory input leads to significant alterations in neuronal activity and widespread circuit reorganization. Microglia actively shape circuits by communicating with neurons and other glia to remove underused synapses. Our findings will identify how microglia shape denervation-induced circuit reorganization, help us better understand healthy adult plasticity, and will identify potential treatments that support recovery after injuries that cause the loss of peripheral sensation.